Intervention-induced plasticity of flexibility and learning mechanisms in ASD

PROJECT SUMMARY
This exploratory project between CNH and Georgetown University leverages the DC-IDDRC
infrastructure and its Neuroimaging, Neurobehavioral and Clinical Translational Cores to test
mechanistic hypotheses about individual differences in the ability to transfer learned knowledge to novel
settings in Autism Spectrum Disorders (ASD). The history of ASD intervention is rife with poor real-world
outcomes and high heterogeneity in generalization success (1). One known contributing factor is executive
dysfunction, particularly behavioral inflexibility (2, 3). Understanding this nexus of learning and executive function
(4) likely holds the key to resolving the generalization challenge in ASD, but it has received little attention. The
proposed project aims to elucidate the association between learning and flexibility by testing whether
intervening to promote flexible behavior in ASD changes learning and associated neural mechanisms.
The scientific premise of the proposed study is that flexible use of learned concepts depends on generating
prototypes, whereas learning tuned to individual exemplars promotes specificity (5, 6). Current models of concept
learning (7) have used computational modeling of individual generalization performance and model-based
functional magnetic resonance imaging (m-fMRI) to attribute prototype-generation to ventral medial prefrontal
cortex (vmPFC) and exemplar-biased learning to the medial temporal lobes (MTL) (8). We propose that
variability in prototype/exemplar learning mechanisms is associated with behavioral flexibility and
explains differences in adaptive and treatment outcomes. We employ a longitudinal case-controlled design
in 54 14-18 year old youth with ASD at 3 time-points 8 months apart, each including m-fMRI during category
learning and behavioral measurement of executive and adaptive function. Aim 1 tests the hypothesis that
individual variation in learning biases (prototype/exemplar) and their neural correlates predicts
behavioral flexibility (Time1) and is stable over time (Time2). Aim 2 tests plasticity of learning
mechanisms induced by a cognitive-behavioral intervention for flexibility (Unstuck-and-On-Target) that
targets development of prototypical knowledge (9). Intervention will strengthen prototype learning, and
associated vmPFC involvement will be associated with better behavioral response to intervention. Aim 3 tests
hypothesis about intervention-induced plasticity of intrinsic functional connectivity. Stronger resting-
state functional connectivity between MTL and vmPFC specifically and network connectivity of the MTL
subsystem of the default mode network (10) will be associated with prototype learning and intervention response.
Our approach is novel, methodologically in the use of individualized characterization of learning mechanisms,
and theoretically in unifying learning and executive function to explain mechanisms of treatment response and
heterogeneity in treatment outcome in ASD. Findings will inform larger investigations of personalized treatments
for promoting adaptive behavior in ASD.